Center for the Science, Technology, and Emerging Health Risks of PAHs

SUMMARY – OVERALL CENTER
The mission of the Oregon State University (OSU) SRP Center is to identify polycyclic aromatic hydrocarbons
(PAHs) in the environment, to characterize their toxicity, and to specify the environmental concentrations below
which they pose no threat to human health. The OSU SRC will study the composition of complex PAH mixtures,
the changes in composition after remediation and natural attenuation, and the implications of PAH mixtures for
human health.
The scientific community does not fully understand the toxicity of structurally diverse, substituted PAHs, nor
the toxicity of complex environmental PAH mixtures. We do not fully understand the degree to which typical
environmental exposures to PAHs threaten human health, particularly in vulnerable populations. We cannot yet
predict the biological effects of complex PAH mixtures. We cannot identify the sources of PAHs. Site managers,
being unable to distinguish between PAHs from legacy sources (such as petrochemical plants) and PAHs from
contemporary sources (such as wildfires), cannot optimize their remediation plans, nor can they evaluate their
remediation efforts. Communities can apply passive sampling devices to determine whether they are being
exposed to PAHs, but they do not know the sources of those PAHs and therefore cannot devise effective plans to
protect themselves.
The OSU SRP Center proposes to answer these scientific questions: What doses of PAHs and a-PAHs (what is
that?) can cause cancer and evoke other adverse responses in humans? Do typical environmental exposures to
PAHs threaten human health? By what biological mechanisms do PAHs exert adverse effects? How does the
toxicity of PAHs depend on their chemical structures? Can long-term zebrafish studies evaluate the
carcinogenicity of PAHs? Can we identify gene expression pathways specific to each category of PAHs? Do
common genetic polymorphisms alter toxicity and subsequent risk to PAH exposure and thereby allow us to
identify susceptible individuals? How does the toxicity of PAHs and PAH mixtures depend on variations in
susceptibility caused by stressors? How can we identify the components in a complex PAH mixture that are
causing additive, synergistic, or antagonistic toxicity? How do novel and abundant a-PAHs contribute to toxicity
in mixtures? Can current remediation techniques reduce human health hazards? How can we develop novel,
safe, sustainable systems that treat PAH mixtures while minimizing the formation of hazardous PAH breakdown
products? How do PAHs move into, through, and away from Superfund sites? How can we identify the sources
of PAHs in ways that not only enable communities to minimize their exposure but also enable remediators to
optimize their remediation plans and evaluate their remediation efforts?

Public health relevance
NARRATIVE – OVERALL CENTER The proposed research provides a rational basis to prioritize sites for remediation without toxicity testing as well as insights into whether bacterial remediation strategies are creating carcinogenic PAH metabolites. It will overcome a major barrier in contaminated site management by enabling risk assessors and site managers to identify (and perhaps remediate) the components of PAH mixtures that are responsible for observed adverse effects. It will advance the field of toxicology toward the ability to determine the toxicity of PAHs on the basis of their chemical structure without resorting to in vivo whole animal testing or even in vitro testing of human cells.